Administrative Core

ADMINISTRATIVE CORE - PROJECT SUMMARY
The purpose of Administrative Core (AC) is to provide the organizational, administrative and fiscal
management of this P01, to develop and implement plans for monitoring the progress, and to effectively
coordinate and communicate within the P01. The AC is essential to ensure that this Program Project is able to
successfully conduct clinical studies and physics and biological research at all the collaborating institutions.
Successful conduct of research in a complex, multi-site program of this magnitude and significance requires
centralized scientific and administrative oversight.
Aims of the Administrative Core are: (1) Provide centralized scientific and administrative oversight,
management and clerical support to all Projects and Cores; organize and conduct the Internal Steering
Committee (ISC) and the annual External Advisory Board (EAB) meetings; and provide support for the weekly,
monthly and as-needed telephone and web-based online conferences. (2) Develop and implement plans for
effective coordination of research; facilitate the exchange of materials (e.g., biological samples), data, models
and information; coordinate communication among researchers; monitor progress; and report progress to the
ISC, EAB and the NCI at appropriate intervals. (3) Provide fiscal management support and financial control
services to individual projects and cores to ensure funds are expended appropriately and provide aid as
needed for personnel management.
Drs. Theodore Hong (MGH) and Radhe Mohan (MDACC), the P01 MPIs, will direct this Core and review
progress and decide policy matters relating to research priorities. The External Advisory Board, comprised of
top scientists in the field, will meet with investigators annually to review scientific progress and the direction of
research and make recommendations for the following year. The ISC, composed of the highly qualified senior
faculty at MGH and MDACC, will meet twice annually and will provide feedback and ensure that resources for
the conduct of the proposed research are available. There will be numerous regularly scheduled scientific and
administrative meetings to coordinate activities at the multiple institutions involved to facilitate research and
monitor progress.

Public health relevance
ADMINISTRATIVE CORE - NARRATIVE The purpose of Administrative Core is to provide centralized scientific and administrative management, financial control services, and clerical and materials management support to all projects and cores. The Administrative Core will coordinate research among projects and cores, monitor progress and resolve issues as they arise. It will provide necessary support for the organization and conduct of the Steering Committee /Internal Advisory Board meetings, the annual Investigator Meeting and Retreat with the External Advisory Board, and monthly or as-needed telephone, video, and web conferences.